An Eyedrop Diagnostic Test for Alzheimer's Disease

PROJECT ABSTRACT
Alzheimer’s disease (AD) affects 6.9 million people in the U.S. alone and is characterized by the development
of amyloid beta plaques, tau neurofibrillary tangles, and neuron loss. This characteristic accumulation of
pathological protein aggregates has led to the development of multiple biomarkers for assessing disease
status in living individuals, providing them with the opportunity to make informed healthcare decisions and to
receive treatment using new FDA-approved drugs that targeting amyloid beta. These biomarkers are also
important indicators for measuring the efficacy of therapeutics in clinical trials. The current approach to detect
these biomarkers is positron emission tomography (PET) which is sensitive and specific. However, PET is a
limited and expensive resource that prevents widespread or frequent biomarker measurements. Other
measurements have been developed or are in development, including detection in cerebrospinal fluid and
blood, yet these have limitations as well. Tauvision recently identified a fluorescent dye that can label
pathological aggregates in the eye and be imaged using standard ophthalmology equipment. Results that
suggest our eyedrop-based, non-invasive assay could be a direct measurement of biomarkers in the central
nervous system. Our approach represents a highly specific, low-cost measurement that could be used to
diagnose and manage AD in a broad population. In this project, we will optimize the structure of the fluorescent
compound to improve its specificity and sensitivity for AD in phase 1, with clear metrics for transitioning to
phase 2. Then, in phase 2, we will validate our approach in animal models of AD and human tissue from
donors with and without AD. This project is a critical first step in translating our potentially breakthrough
approach to fill the diagnosis gap in AD.

Public health relevance
PROJECT NARRATIVE Diagnosing neurodegenerative disorders such as Alzheimer’s disease is complex, yet timely diagnosis is critical for patient decision-making, access to FDA-approved therapeutics, and enrollment in clinical trials. Biomarkers for Alzheimer’s disease can assist clinicians in this process, but current options are limited, invasive and expensive. This project will optimize and validate a novel eyedrop-based test to greatly improve our capacity to diagnose Alzheimer’s disease and extend the benefits of sensitive and specific biomarkers to all aging individuals.